Determining the influence of metformin treatment on mitochondrial calcium flux during aerobic exercise training of healthy, aging rats

Project Summary
Metformin (MET), the most widely prescribed medication for treating type 2 diabetes, is increasingly recognized
for its healthspan extension effects. If MET is to be an effective healthspan extending drug, it is critical to
understand the effects of MET during periods of relative health and how it interacts with other healthspan-related
interventions such as exercise. Studies that have examined the MET-exercise interaction overwhelmingly show
that MET inhibits the positive effects of aerobic exercise training (AET), but the mechanisms behind this effect
are still unknown. Our recent clinical trial also demonstrated that subjects with the highest mitochondrial complex
1 supported respiratory function and insulin sensitivity were the most negatively affected by MET treatment with
an exercise intervention. The proposed study will determine if the detrimental effects of MET treatment on
skeletal muscle adaptations to AET involves altered calcium handling. Calcium handling is imperative for
mitochondrial function, adaptations to exercise, and muscle health during aging. This project is significant
because it further defines the context-specificity of MET benefits on healthspan. We hypothesize that MET
treatment will impede calcium flux into the mitochondria during exercise training in aging rats, inhibiting the
positive adaptations to AET. To test this hypothesis, we will use a rat model with genetic selection for high
intrinsic aerobic capacity (HCR) because they represent, by many outcomes, healthy human subjects. The
Specific Aims are to: 1) Determine how MET treatment alters mitochondrial calcium flux during AET and 2)
Determine if MET treatment during AET alters the turnover of calcium handling proteins and structures regulating
calcium kinetics. We will assess in vivo cytosolic and mitochondrial calcium kinetics using 2-photon fluorescence
microscopy. Changes to mitochondrial calcium flux and function of skeletal muscle with and without 12 weeks of
AET and/or MET will be measured using an Oroboros O2K. To determine if MET changes adaptations to AET,
we will develop a targeted mitochondrial proteomics panel to measure the quantity and turnover of mitochondrial
and calcium-handling proteins. We will also use a novel optic clearing technique in combination with light sheet
microscopy to establish changes to mitochondrial-associated membrane contacts (MAM) structure and location
with and without MET. We expect that with MET treatment, animals will have a lower rate of mitochondrial
calcium uptake coupled with lower respiration, and that this inhibition will be more prominent in the exercised
animals. Additionally, we expect MET will negatively impact the mitochondrial proteome related to calcium flux
and hinder improvements associated with MAM number and distance to calcium release units in response to
exercise. Successful completion of these aims will allow us to uncover mechanisms that contribute to the
inhibition of AET adaptations with MET treatment in aging animals. Key training aspects include novel
bioenergetic, flux and proteomic assessments of calcium handling in mitochondria that are crucial for my
development to an independent investigator focused on targeting mitochondria for muscle aging.

Public health relevance
PROJECT NARRATIVE The current proposal seeks to understand why metformin inhibits adaptations to aerobic exercise training in healthy, aged individuals. The project proposes that metformin negatively impacts calcium handling in skeletal muscle, which contributes to the inhibition of adaptations to aerobic exercise. Understanding these mechanisms could help determine strategies to maintain the positive effects of aerobic exercise training in healthy aging subjects, who may benefit from metformin treatment and, more importantly, who may not.